Sickle cell disease severity prediction from the magnetic signature and hemoglobin content of blood cells

SUMMARY
Sickle cell disease (SCD) is the most prevalent genetic blood disorder, caused by a single point mutation in the
β-globin subunit of hemoglobin (Hb), the protein contained in red blood cells (RBCs) responsible for oxygen
delivery to the tissues. The condition affects millions of people worldwide, primarily of African ancestry or Blacks,
who often see themselves treated unfairly when seeking medical care due to the color of their skin. The major
complication of the disease is the development of acute pain episodes known as vaso-occlusive crisis (VOC),
that result in severe end-organ damage and a shortened lifespan. VOC is caused by vascular occlusion due to
the accumulation in the blood of sickle-shaped, rigid, RBCs that become trapped in capillary blood vessels. Since
VOC is responsible for an estimated 95% of SCD hospitalizations, and it is also employed as a key predictor of
death, it is critical to find a way to drive early detection of VOC to support preventative interventions, better
manage the condition and improve the life quality and expectancy of SCD patients. It has been recently
demonstrated the protecting role of patrolling monocytes (PMo) in SCD, as they scavenge endothelial-adherent
sickle RBCs. We hypothesize that both irreversibly deoxygenated sickle RBCs and PMos count, their magnetic
susceptibility, and their intracellular analysis (in terms of iron (Fe), Hb, and RBC content) could be used to predict
the potential development of VOC. Due to the magnetic properties of (deoxygenated) Hb, and by extension,
irreversibly deoxygenated sickle RBCs, magnetism could be exploited for the simultaneous count and analysis
of both cell types (RBCs and monocytes) in SCD and to relate these parameters to the development of VOC.
Our recent research has demonstrated a difference between the magnetic/physical properties of sickle RBCs
and healthy RBCs, which becomes more evident when the SCD patients are in crisis. We have also
demonstrated for the first time the paramagnetic properties of a subset of monocytes, and the higher magnetic
susceptibility of PMos in comparison to classical monocytes. Thus, this project aims to study the differences
between the number, magnetic properties, size/density, and RBC/Hb/Fe content of RBCs and monocytes
obtained from healthy blood donors and patients with SCD at 5 different clinical states (from least severe to
VOC), and will try to establish a relationship between these cells’ properties and the development of VOC. We
will employ our custom, permanent magnet-based devices for the analysis of the cells and their separation, using
fast, inexpensive, and label-free approaches. We expect that single-cell magnetometry can be employed to gain
a better understanding of the factors leading to the development and potential prediction of VOC, to determine
the severity of the disease and to be used as a quantitative measure for the diagnosis of VOC. Our studies will
also provide guidelines for the design of a novel magnetic device for the separation and quantification of magnetic
cells in the blood of SCD individuals with potential diagnostic value.

Public health relevance
NARRATIVE This project aims to study the magnetic character of red blood cells and monocytes in sickle cell disease (SCD), with an emphasis on analyzing their magnetic susceptibility and Hb/Fe content, and the relationship of these parameters to the severity of the disease (development of vaso-occlusive crisis, VOC). The knowledge gained from this study can be used to understand the role of these cells in the pathophysiology of VOC, with the goal of developing inexpensive systems based on permanent magnets to determine the severity of SCD and the development of VOC.